A clinical decision tool to optimize the selection of antibiotics for patients with rifampicin-resistant Tuberculosis

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB) remains a major public health concern worldwide with more than 1.4 million estimated
deaths in 2022. Despite recent declines in global TB incidence, the emergence and spread of drug-resistant
Mycobacterium tuberculosis have complicated the control of TB in many settings. Drug-resistant TB is
associated with higher mortality and morbidity and requires longer duration of treatment with multiple second-
line antibiotics that often have severe side effects. With the widespread adoption of Xpert MTB/RIF (a
molecular test for the rapid detection of TB and resistance to rifampicin) over the last 10 years, a growing
number of individuals with rifampicin-resistant TB (RR-TB) are being detected and notified in many high-
burden settings. To determine an effective treatment regimen for a patient with RR-TB, the selection of
antibiotics would ideally be made based on the results of drug susceptibility tests (DSTs). However, because of
limited access to DSTs and lengthy delays in receiving DST results, the treatment of RR-TB in most settings
remains empiric (i.e., without the results of DSTs) and according to standardized second-line regimens, which
are endorsed at the global level. This results in many patients with RR-TB receiving suboptimal treatments,
which exposes them to a higher risk of treatment failure, increased toxicity, and the emergence of additional
resistance. To mitigate these issues, this project develops a clinical decision support (CDS) tool to optimize
medications for individuals with RR-TB, at the point of care, and based on the patient’s basic demographic and
clinical information (e.g., age, residence in urban or rural area, and history of TB treatment). The proposed tool
combines spatiotemporal machine learning and decision models to synthesize data from clinical trials of anti-
TB drugs, local surveillance systems of drug-resistant TB, and studies of cost and loss in quality of life due to
illness, treatment toxicity, treatment failure, and emergence of additional resistance. Employing a user-
centered design approach with direct input from stakeholders (e.g., TB practicing physicians, health services
researchers, laboratory specialist, and policymakers), this project develops a prototype of a user interface for
the proposed CDS tool with the potential to be implemented in routine clinical care and a follow-up randomized
clinical trials. This project also evaluates the effectiveness and cost-effectiveness of treatment
recommendations that are customized according to the local epidemiology of drug-resistant TB and/or
according to patients’ basic demographic and clinical information compared with the standardized treatment
regimens, which are determined at the global level. The proposed research is significant because it provides
TB clinicians in low-resource, high-burden settings with essential evidence and tools to improve the treatment
outcomes of patients with RR-TB while containing cost and slowing the spread of drug-resistant TB.

Public health relevance
PROJECT NARRATIVE Many patients with drug-resistant tuberculosis in high-burden settings receive suboptimal treatment due to the lack of access to drug-susceptibility tests or long delays in receiving test results. The proposed research describes the development of a clinical decision support tool to optimize the empiric treatment of patients with rifampicin-resistant tuberculosis based on patient characteristics, the local epidemiology of drug-resistant tuberculosis, and the cost and toxicity of anti-TB drugs.